Mechanisms of Hormonal Regulation of the Sodium Chloride Cotransporter

DESCRIPTION (provided by applicant): The thiazide-sensitive sodium chloride cotransporter (NCC) is one of the key determinants of salt balance and thus systemic blood pressure. However, in contrast to other important effectors of salt balance we know little about how hormonal and physiological signals alter activity of this cotransporter. Preliminary data demonstrates the role of the ERK1/2 MAPK (Extra-cellular signal-Regulated Kinases 1 and 2 Mitogen-Activated Protein Kinases) pathway in the ubiquitination and endocytosis of NCC. With-No-Lysine Kinase 1 and 4 (WNK1 and WNK4), Ste20-related proline alanine-rich kinase (SPAK) and Oxidative Stress Response-1 (OSR1) are also important regulators of NCC, and there is data that some hormones regulate NCC. However, a link between hormones and the intracellular pathways that mediate the effects of hormones on NCC has not been established. The broad hypothesis of the proposed investigation is that NCC is subject to hormonal regulation that proceeds through modulation of the kinases ERK1/2, SPAK/OSR and WNKs. Aim 1 will define the hormonal regulation of NCC through activation of ERK1/2 MAPK. ERK1/2 MAPK will be examined as a central mediator of the hormonal/physiological effects of Epidermal Growth Factor (EGF) and the Calcium-sensing Receptor (CaSR) on NCC. The mechanism of ERK1/2 activation and the roles of ubiquitination and endocytosis in this process will be thoroughly examined for each hormone, tracing a pathway from hormonal stimulus to functional effect. Aim 2 will determine the hormonal regulation of NCC by Aldosterone through ERK1/2 MAPK and SPAK/OSR and the mechanisms underlying these effects. ERK1/2 inhibition and SPAK/OSR activation by Aldosterone may lead to increased NCC activity. The role of WNKs in these pathways will be thoroughly examined. Aim 3 will determine the underlying molecular mechanisms mediating hormonal regulation of NCC by Angiotensin II. The roles of each of these kinase pathways will be examined with a particular emphasis on WNKs. Mammalian cell culture, isolated tubule microperfusion and whole animal experimentation will be utilized to examine effects at the cellular/molecular, tubular and organismal level. Knowledge of hormonal regulation of blood pressure has played a critical role in the development of new therapies to treat hypertension, the single risk factor that contributes the most to worldwide mortality. These studies will provide vital information on the regulation of this important effector of blood pressure homeostasis.

Public health relevance
PUBLIC HEALTH RELEVANCE: The sodium chloride cotransporter (NCC) is an important salt absorptive pathway in the mammalian kidney that is the site of action of one of the most effective classes of anti- hypertensive medications and plays a key role in genetic disorders of hypertension. Despite the importance of this cotransporter in human disease, we know little about its hormonal regulation. This investigation of the hormonal regulation of this key effector of blood pressure will provide invaluable insight into the pathogenesis of Hypertension. The sodium chloride cotransporter (NCC) is an important salt absorptive pathway in the mammalian kidney that is the site of action of one of the most effective classes of anti- hypertensive medications and plays a key role in genetic disorders of hypertension. Despite the importance of this cotransporter in human disease, we know little about its hormonal regulation. This investigation of the hormonal regulation of this key effector of blood pressure will provide invaluable insight into the pathogenesis of Hypertension. __SpecificAimsTextDelimiter__ RESEARCH PLAN A. Statement of Hypothesis and Specific Aims HYPOTHESIS: The thiazide-sensitive sodium chloride cotransporter (NCC) is one of the key determinants of salt balance and thus systemic blood pressure. However, in contrast to other important effectors of salt balance we know little about how hormonal signals alter activity of this cotransporter. We utilized a mammalian cell model to demonstrate the role of the ERK1/2 MAPK (Extra-cellular signal-Regulated Kinases 1 and 2 Mitogen-Activated Protein Kinases) pathway in the ubiquitination and endocytosis of NCC. With-No-Lysine Kinase 1 and 4 (WNK1 and WNK4), Ste20-related proline alanine-rich kinase (SPAK) and Oxidative Stress Response-1 (OSR1) are also important regulators of NCC, and there is data that some hormones regulate NCC. However, a link between hormones and the intracellular pathways that mediate the effects of hormones on NCC has not been established. Our recent generation of a mammalian cell model that does not require a chloride-free pre-incubation prior to functional assessment of NCC has provided an opportunity to study the mechanisms of hormonal regulation of NCC. Based on published data and preliminary studies we hypothesize that NCC is subject to hormonal regulation that proceeds through the activation of the kinases ERK1/2, SPAK/OSR and WNKs. We propose that ERK1/2 MAPK activation is a central mediator of the hormonal effects of Epidermal Growth Factor (EGF) and the Calcium-sensing Receptor (CaSR) on NCC (Aim 1). The increased ubiquitination and endocytosis of NCC induced by ERK1/2 leads to decreased surface expression and salt absorption. Conversely, ERK1/2 inhibition by Aldosterone leads to increased sodium absorption. Additionally we hypothesize that Aldosterone also stimulates NCC through effects on the WNK1/SPAK/OSR cascade of kinases resulting in direct phosphorylation and activation of NCC (Aim 2). Lastly we propose that Angiotensin II modulates WNKs resulting in increased surface expression and increased sodium absorption (Aim 3). SPECIFIC AIMS: 1) To rigorously define the hormonal regulation of NCC through modulation of ERK1/2 MAPK and the molecular mechanisms underlying effects of hormones on ERK1/2 and effects of ERK1/2 on NCC. The mechanism of ERK1/2 activation and the roles of ubiquitination and endocytosis in this process will be thoroughly examined for each hormone, tracing a pathway from hormonal stimulus to functional effect. Hypothesis: Hormonal activation of the ERK1/2 MAPK pathway results in increased ubiquitination of NCC, increased endocytosis and decreased sodium chloride absorption by NCC. A) Define the molecular mechanisms underlying the CaSR-mediated suppression of NCC. B) Define the molecular mechanisms underlying the EGF-mediated and ERK1/2 MAPK dependent suppression of NCC. Transactivation of EGF receptor (EGFR) by CaSR will also be examined. C) Examine in vivo effects of these hormone/ERK pathways utilizing isolated tubule microperfusion and assessment of ERK1/2 activation via immunohistochemistry. 2) To determine the hormonal regulation of NCC by Aldosterone through ERK1/2 MAPK and SPAK/OSR and the mechanisms underlying these effects. Hypothesis: ERK1/2 inhibition and SPAK/OSR activation mediate stimulation of NCC activity by Aldosterone resulting in increased sodium chloride absorption. A) Define the contribution and mechanisms of ERK1/2 MAPK inhibition by Aldosterone on the increase in NCC-mediated sodium chloride absorption. The role of Glucocorticoid Induced Leucine Zipper protein (GILZ) in transducing the Aldosterone signal to ERK1/2 will be thoroughly examined. B) Define the contribution and mechanisms of SPAK/OSR activation by Aldosterone on the increase in NCC-mediated sodium chloride absorption. The role of WNKs in transducing the Aldosterone signal to SPAK/OSR will be examined as well. C) Examine the transgenic SPAK knockout mouse for alterations in blood pressure, salt sensitivity, aldosterone sensitivity and phosphorylation of NCC as compared to wild type. Additionally isolated tubule microperfusion of transgenic mice will be done to assess DCT sodium flux versus wild-type mice with and without Aldosterone. 3) To investigate the underlying molecular mechanisms mediating hormonal regulation of NCC by Angiotensin II. Hypothesis: Angiotensin II modulates kinase effects on NCC resulting in increased surface expression of NCC and increased sodium chloride absorption. The involved kinase pathways and the molecular mechanisms of Angiotensin II mediated increases in NCC activity in mDCT15 cells will be determined. ERK1/2, WNKs and SPAK/OSR are potential mediators of Angiotensin II effects on NCC. Assessment of kinase and/or NCC activation via immunoblotting and with total and phospho-ab will also be done. Once the relevant pathways have been determined, tubular effects of the identified hormone/kinase pathways will be assessed utilizing isolated tubule microperfusion